The Early Growth and Development Study Pediatric Cohort

7. Project Summary/Abstract
Increasing evidence suggests that exposures from pregnancy through age 5 can result in health deficits and
lead to life-long consequences. We propose to leverage and build upon a unique existing “dual-family”
adoption design to isolate early environmental exposures from heritable influences on familial clustering of
health problems to contribute to ECHO's overall goal of investigating the role of early life exposures and
underlying biological mechanisms in childhood health and disease. Our pediatric sample will be drawn from
three cohorts of children (N = 1,201 children) who have been followed prospectively since birth in the Early
Growth and Development Study (EGDS). The EGDS cohorts consist of two types of families: adoptive families
in which the child is not genetically related to either rearing parent (n = 790 children), and biological families in
which the child is genetically related to the rearing parent (n = 411 children). Within these families, we have n =
927 sibling pairs of two types: (1) siblings living apart, in which one sibling was adopted at birth and reared with
genetically unrelated parents and the other sibling remained in the biological home and was reared by the
biological parent from birth (n = 365 pairs), and (2) siblings living together either in the adoptive home or the
biological home (n = 562 pairs). We have established a reliable research infrastructure, exceptional
measurement of the early childhood family social environment, medical records data, DNA and salivary cortisol
samples, high retention rates, and reliable and transparent data-sharing methods. We will use our well-
established prospective adoption sample to (a) help clarify causal inferences about environmental influences
on neurodevelopment and obesity, and (b) explore the unfolding interplay between inherited child
characteristics and environmental influences from birth to adolescence. In cohorts in which children are reared
by biological parents, it is difficult to differentiate the role of the social environment from that of genetic
influences. Our dual-family design addresses this fundamental confound. In this application, we emphasize the
Focus Area of Neurodevelopment; however, our sample and approach are also well suited for examining
environmental influences on Obesity and Airways Focus Areas, as secondary and tertiary foci. In the UG3
phase, we will (1) demonstrate the feasibility of rerecruiting families into ECHO by rerecruiting and consenting
families of 1,000 children; (2) prepare for the UH3 period by conducting pilot scale coding of adult medical
records, piloting our geocoding system, conducting preliminary analyses, and developing and testing a brief
measure of social environmental adversity; and (3) collaborate and plan with the ECHO Steering Committee. In
the UH3 period, we will (1) build on the UG3 activities by enhancing our assessment of environmental and
inherited risks in the EGDS cohort through in-home and phone assessments of neurodevelopment, obesity,
airway function, and the social environment; and (2) conduct ECHO consortium-wide activities as determined
by the ECHO Steering Committee.

Public health relevance
8. Project Narrative It is clear that both biological and environmental factors play a role in the unfolding of health disorders beginning very early in development, yet the specific mechanisms and processes that lead to healthy development versus illness are not well understood. The proposed “dual-family” adoption sample is an essential component of the ECHO pediatric cohort study because our design allows for increased precision in isolating environmental influences on child health outcomes and understanding how such influences affect and are affected by biological mechanisms. When combined with other ECHO pediatric cohorts, the data generated and analyses conducted in the proposed study will lead to improved guidance for future prevention efforts aimed at offsetting inherited risks and maximizing inherited strengths to promote healthy development.